3D Chromatin Studies in Pediatric B Cells To Study the Genetics of Autoimmunity

Abstract – The purpose of this small project is to gather preliminary data we need to support a range of
projects relating to autoimmunity in children, and particularly to pediatric systemic lupus erythematosus (pSLE).
Specifically, we need to generate 3D chromatin maps on B cells from children in order to carry our work
forward. The project also addresses the serious need for reference genomic data sets that can be used in a
broad spectrum of research aimed at understanding childhood-onset, immune-driven diseases.
The problem we face is a common one in pediatrics and limits our ability to rigorously pursue genetic and
genomic translational studies: the uncertainty as to whether publicly available genomic data sets (e.g., from
Roadmap Epigenomics) can be used as comparison data to interpret similar data generated in children. The
limitations in the use public data sets therefore represent a “tax” on the research of pediatric investigators that
is not always required of investigators studying adult or adult-onset diseases, where a broad variety of genomic
data sets are already available, including those from diseased tissues. In this project, we will produce an
reference data set that will be useful to a range of investigations into immune-based diseases that occur in
children.
Our work in pediatric autoimmune diseases is aimed at identifying causal variants on genetic risk haplotypes
as well as the genes impacted by those variants. These target genes may not be those nearest the causal
variant, or even genes on the risk haplotype. They will almost invariably be genes within the same chromatin
loop or topologically associated domains, chromatin loop structures that are anchored by the CCCT binding
factor (CTCF) and cohesin. Identifying these loop structures is therefore a key step in identifying target genes.
This project is aimed to identify these structures, and the genes expressed within them, in pediatric samples.
Our approach is straightforward. We will use CTCF Cut-and-Run and HiChIP to identify CTCF-anchored
loop structures in the B cells of healthy children. We will also perform RNA sequencing on these same samples
in order to identify the genes expressed within loops. At the completion of this 2-year project, we will have
obtained the essential data that we need to rigorously interpret the studies we already have under way in pSLE
and will have provided the field with an essential tool for future investigations into autoimmunity in children.

Public health relevance
Narrative – Federally-funded projects like Roadmap Epigenomics have provided investigators with a treasure trove of genomic reference data that can be used to understand a broad spectrum of diseases. However, because of the development of organ systems, especially the immune system, over time, it is uncertain how useful these data sets are as references for diseases involving children. In this project, we will generate a pediatric-specific genomic data set in B cells, an important immune cell, to assist investigators in better understanding diseases like systemic lupus and type 1 diabetes in children.